Dose based aspirin pharmacokinetics and pharmacodynamics in pregnancy and association with pregnancy outcomes

PROJECT SUMMARY
Background: Aspirin is recommended in high risk pregnancies to reduce the risk of preeclampsia
and preterm birth, but up to 20% will still have these adverse outcomes. Recommendations for
aspirin dose range from 75mg-162mg daily. Gaps in knowledge regarding pregnancy specific
aspirin pharmacology and relationship between aspirin response and pregnancy outcome limit
optimal use of aspirin to prevent adverse perinatal outcomes.
Objective: 1) Determine platelet inhibition in response to increased dosing of aspirin through
gestation and factors impacting aspirin response. 2) Determine aspirin population
pharmacokinetics (PK) and PK/PD (pharmacodynamic) relationship through gestation. 3)
Determine association between aspirin response and perinatal outcomes.
Methods: This is a randomized controlled trial of N=300 high risk singleton pregnancies
randomized to either 81mg BID or 162mg daily of aspirin, initiated <16 weeks, and continued until
36 weeks gestation. Participants will have aspirin response assessed at baseline, 2-4 weeks after
aspirin initiation and at 28-32 weeks gestation. Aspirin response will be assessed with PFA-100
epinephrine closure time (primary) and urine and serum thromboxane (secondary). A subset
(N=50) will be enrolled in a PK study that involves 8-hour study visits in the 1st and 3rd trimester.
Expected Results: Analyses for aims will include the two arms of the randomized trial along with
a third arm of N=96 high risk singletons who took 81mg aspirin daily (already complete). Aim 1
will compare aspirin response between dosing groups and identify individual covariates that
impact aspirin response. Aim 2 will develop a pregnancy model for aspirin PK and PK/PD. Aim 3
will examine the relationship between aspirin response and perinatal outcomes
Impact: 1) Novel paradigm in clinical care, adjusting aspirin dosing based not only on the risk for
preeclampsia/preterm birth, as currently suggested, but also on anticipated response to aspirin in
pregnancy based on individual factors. 2) Inform development of a novel clinical paradigm with
use of aspirin response to predict preterm birth, identifying patients who may benefit from dosing
adjustment, adjunctive therapies, or additional monitoring. 3) Inform future clinical trials through
computational modeling for rationale aspirin dose selection. 4) Inform novel research pathways
of antiplatelet therapies in pregnancy through identification of relevant pharmacodynamic
markers, individual covariates, and placental mechanisms of action. Ultimately, we will improve
the management of high-risk pregnancies, leading to healthier mothers and babies.

Public health relevance
PROJECT NARRATIVE Aspirin is recommended in high risk patients to reduce the risk of preeclampsia and preterm birth, which are leading causes of both maternal and neonatal morbidity and mortality, but up to 20% will have these adverse outcomes despite therapy. Gaps in knowledge regarding pregnancy specific aspirin pharmacology and the relationship of aspirin response and pregnancy outcome, along with a lack of consensus on aspirin dosing has limited the effective use of this intervention. We aim to apply principles of clinical pharmacology to determine how to optimally utilize this low cost medication to improve maternal/child health outcomes.